An ethno-epidemiological study of the implementation and effectiveness of an innovative and comprehensive response to the evolving overdose epidemic

Overdoses deaths have increased sharply in Canada and the US over the past decade. While fentanyl is a critical driver of North America’s overdose epidemic, rising fentanyl-stimulant polysubstance use and ongoing drug supply changes (fluctuating fentanyl potency, adulteration of fentanyl with novel psychoactive substances (NPS)) are worsening the situation and pose challenges to overdose prevention and substance use treatment approaches. There has been a lack of research into how these emerging dynamics shape overdose risk and the effectiveness of overdose responses, as well as how services are being adapted in response to these challenges. Based in Vancouver, Canada, this study will employ an innovative ethno-epidemiological approach to address this critical research gap by: (1) characterizing how evolving drug use patterns and supply changes impact overdose risk; (2) examining how changing drug use patterns and drug supply changes interact with contextual drivers to impact the effectiveness of overdose prevention interventions; and (3) exploring influences on treatment outcomes for existing and emerging opioid agonist treatment (OAT) approaches among fentanyl-stimulant polysubstance-using and NPS-exposed people who use drugs (PWUD). Vancouver is the ideal setting to undertake the proposed research. Vancouver had implemented innovative overdose prevention and addiction treatment interventions that led to significant decreases in overdose deaths and that were later implemented – or are now being considered – elsewhere in the US and internationally, including drug checking programs and low-threshold oral and injectable OAT. This comprehensive overdose response is being adapted in response to rising overdose deaths attributed to fentanyl-stimulant polysubstance use and drug supply changes, including by expanding drug-checking (benzodiazepine and xylazine testing strips), community-based overdose prevention, and OAT options (e.g., oral and injectable OAT) and integrating OAT with contingency management and detoxification services. This study will be nested within the research infrastructure of the BC Centre on Substance Use, which includes NIDA-funded, longitudinal cohort studies of PWUD and a NIDA-funded drug-checking program evaluation. This approach will enable epidemiologically-informed sampling and targeted recruitment of PWUD and facilitate the integration of qualitative data and cohort-based and drug surveillance data. Extending our ethno-epidemiological research to examine how a comprehensive response to the overdose epidemic is being adapted to rising fentanyl-stimulant polysubstance use and drug supply changes will result in a more nuanced and complete understanding of influences on the effectiveness of the overdose response than is possible through epidemiological research alone. The proposed research will generate evidence critical to optimizing the response to the overdose epidemic and is aligned with NIH and NIDA strategic priorities and the federal government’s focus on fentanyl.

Public health relevance
PROJECT NARRATIVE This study will employ an ethno-epidemiological approach to examine how drug supply changes and rising fentanyl-stimulant polysubstance use impact overdose vulnerability and the effectiveness of a comprehensive response to the overdose epidemic in Vancouver, Canada, including robust harm reduction and addiction treatment interventions. This study operates in connection with three NIDA-funded cohort studies and a NIDA- funded drug-checking evaluation project, and involves the integration of ethnographic and qualitative data with clinical, behavioral, and drug surveillance data. This study addresses critical research gaps by examining emerging dynamics fueling the overdose epidemic, and will generate evidence critical to optimize public health responses.